Defining mechanisms of CD8 T cell exhaustion in T1D

PROJECT SUMMARY/ABSTRACT
A critical barrier to treating Type 1 Diabetes (T1D), an autoimmune disease in which the islet beta cells are
destroyed by immune cells, is understanding the heterogeneity of disease. One source of immune
heterogeneity recently identified across recent onset T1D subjects is the presence of partially exhausted CD8
T cells in subjects with beneficial response to anti-CD3 therapy (Long, et.al Science Immunology). Likewise,
subjects with slower disease progression have great frequencies of islet-specific CD8 T cells with more
features of exhaustion. Yet, the mechanisms underlying exhaustion in T1D are not well understood. By
contrast, in chronic viral settings it is well established that the IL-2/IL-15 axis is involved in differentiation and
persistence and CD8 exhaustion: increased IL-2 availability prevents differentiation, while response to IL-2/IL-
15 is required for persistence. In T1D, we published seminal studies along with others that link alterations in
the IL-2/IL-15 axis with T1D. Here, we find that T1D subjects with lower frequencies of exhausted CD8 T cells
have higher levels of CD4 IL-2 production and lower levels of IL-15 response in CD8 exhausted cells. Thus, IL-
2/IL-15 defects associated with T1D present a unique opportunity to elucidate the role of IL-2 on CD8
exhaustion. We hypothesize that alterations in the IL-2/IL-15 axis in T1D lead to decreased
differentiation into islet-specific exhausted CD8 T cells and reduced persistence. We will test this
hypothesis in two focused aims using samples from well curated human cohorts of established T1D, pre-
clinical T1D and healthy control (HC) subjects, and multi-dimensional single cell approaches including mass
cytometry (CyTOF), RNA-seq and ATAC-seq combined with innovative systems immunology approaches. In
Aim 1, we propose to elucidate mechanisms of increased CD4 IL2 production that lead to reduced exhaustion
at different stages of disease. In Aim 2, we will elucidate mechanisms of reduced IL-12/IL-15 response in
exhausted CD8 T cells that results in limited persistence of exhaustion. Successful completion of these aims
will 1) advance our understanding of CD8 T cell exhaustion as an understudied form of tolerance in T1D, 2)
improve our understanding of immune factors contributing to T1D disease progression, and 3) provide the
foundation for the development of therapies designed to promote exhaustion.

Public health relevance
PROJECT NARRATIVE Type 1 diabetes (T1D) is an autoimmune disease that affects over 3 million Americans, for which there is no cure, resulting in lifelong treatment with insulin. This project will address the gap in knowledge about the mechanisms responsible for T1D progression. Understanding these mechanisms is essential to development of new therapies to treat and prevent T1D.